Repetitive sequences drive genome variation and plasticity

ABSTRACT
The mechanisms by which mammalian genomes maintain stability through generations and divisions are
important, and de-regulation of these cellular programs can lead to somatic mosaicism, disease, and cancer.
Many multicellular eukaryotic genomes are replete with repeats that include ancient repeat mobility events,
actively mobilizing transposable elements, and large segmentally duplicated regions. Human variation caused
by transposable element mobility and structural rearrangements between repeats comprises more than a quarter
of variants larger than fifty base pairs in the human population. These structural variants can lead to the insertion
of promoter sequences, transcription factor binding sites, and even gene duplication events in mice and humans.
Thus, mammalian genomes are comprised largely of repeat sequences, yet the role these sequences play in
generating genomic instability, the factors that deter this instability, and the gene regulatory differences due to
repeat variation are still poorly understood. Moreover, much of our knowledge on the genomic stability of repeats
is derived from studies in yeast or from the use of reporter assays that interrogate discrete repeat sequences
and distances. In the past five years, we have developed a robust research program using molecular genomics
combined with computational biology to investigate the consequences of repetitive sequences on human and
mouse genomes. In the next five years, we will identify repeat mediated rearrangements across large numbers
of individuals and diverse species using our established approaches, interrogate how transposons have
diversified gene regulation across a half million years of mouse evolution and the epigenetic and transcriptional
consequences of this variation, and will identify the guardians of repeat mediated genomic stability and mobility.
We will approach the proposed work with a diverse team of computational biologists, tool developers, graduate
students, post-baccalaureate researchers, and summer students. The long-term goals of our research are to
understand how mammalian genomes guard against variation in the context of repetitive sequences and how
repeats can diversify genomes and gene regulation in short evolutionary timespans.

Public health relevance
PROJECT NARRATIVE DNA rearrangements—such as deletions, duplications, and inversions—can negatively impact human health and cause disease, and repetitive sequences underlie much of this genomic variation. This proposal will support a vibrant lab with individuals from multiple career stages in their investigation of the role of transposable elements and other large repeats in generating variation, diversifying transcriptomes, and in changing the regulatory landscape of closely related species. This project will also identify genomic surveillance mechanisms that currently guard genome stability in repetitive mouse and human genomes.